INNER CITY ASTHMA STUDY

Asthma is the most common chronic disease of childhood, and its rates are even higher among inner city children. The purpose of this study is to evaluate the effectiveness of 3 different approaches to treating asthma in inner city children: augmented ususal care, coordinated care, and coordinated care plus environmental modification.